Fatty acid metabolism in disease models of mitochondrial fatty acid synthesis deficiency.

Title:
Fatty acid metabolism in disease models of mitochondrial fatty acid synthesis deficiency
Project summary/abstract:
Rare genetic diseases cause 35% of deaths in children under 1 year of age and are a significant cause of
pediatric hospital admissions. Primary mitochondrial diseases are one group of inborn errors of metabolism
(IEM) caused by germline mutations in genes involved in metabolism. While individually rare, IEMs collectively
affect 1 in 5,000 children making them relatively common as a group. Despite their prevalence, mitochondrial
disorders are difficult to diagnose and treat, in part because of our often-poor understanding of the underlying
molecular etiology.
Deficiencies in the mitochondrial fatty acid synthesis (mtFAS) pathway are an emerging group of
childhood-onset mitochondrial diseases with particularly understudied pathophysiology. Genetic variants in
mtFAS genes cause Mitochondrial enoyl reductase Protein Associated Neurodegeneration (MePAN)
syndrome, which presents with severe developmental delays, seizures, hypotonia, hearing and vision loss, and
a plethora of systemic problems. mtFAS produces both lipoic acid (an important co-factor for several enzymes)
and long-chain fatty acids that support electron transport chain function. However, the cellular roles of mtFAS
products and the pathway’s function in diverse cellular contexts are still unclear, preventing the development of
rationale-based therapies for mtFAS deficiency. To better treat MePAN syndrome, we need new approaches.
Toward this overarching goal, we will use two complementary methodologies to identify potential therapeutic
targets that rescue growth and development in mtFAS-deficient patient models.
We have developed a novel, organismal model of MePAN syndrome by recreating patient mutations in
Caenorhabditis elegans, which result in marked developmental delays. We show that we can use this model to
perform genome-wide screens in whole organisms, and successfully recover genetic suppressors of the
phenotypes caused by mtFAS patient variants. In parallel, we have performed preliminary CRISPR/Cas9
screens in mtFAS-deficient cells and found that loss of fatty acid oxidation pathway genes, as well as genes
encoding subunits of the mitochondrial electron transport chain, rescues growth in mtFAS-deficient cells. We
propose to test the utility of these findings in a panel of primary patient fibroblasts, and to expand our analyses
by performing genome wide loss of function and CRISPRa screens to identify additional pathways of
suppression. Together, these experiments will lay the groundwork for future development of therapeutics for
mtFAS-deficient patients and their families.

Public health relevance
Public Health Statement Inborn errors in metabolism (IEM) are genetic disorders that cause developmental delays, systemic disease, and sometimes death in children, yet many have no standard of care. Children with deficiencies in the mitochondrial fatty acid synthesis (mtFAS) pathway exemplify this problem. To advance the goal of developing treatment strategies for these children and their families, here we propose to mechanistically characterize approaches to improve growth and development in models of mtFAS deficiency derived from pediatric patients.